Clinical progression and predictors of outcomes in congenital Zika syndrome

PROJECT SUMMARY/ABSTRACT
Although rates of congenital Zika virus syndrome (CZS) have declined since the 2015–2016 Zika virus
(ZIKV) outbreak in Brazil, transmission of the virus still occurs, with nearly 9,000 cases reported already in
2023. Without global eradication, the threat of another large outbreak exists. Longitudinal research is
necessary to better understand the long-term impact of CZS and factors associated with various health
outcomes. For this application, we will extend our successful collaboration between RTI International and
Altino Ventura Foundation (FAV), to include the University of North Carolina and Purdue University to bring
new, expanded expertise in imaging, EEG, and heart rate sustained attention. We will continue to evaluate
the impact of severe CZS on the medical and developmental outcomes for 187 children who have been
followed since birth. Our cohort, now entering middle childhood, is the largest sample of children with well-
documented CZS to be followed longitudinally since infancy. We will examine the evolution of the primary
clinical signs of CZS (brain, ocular, orthopedic) and assess the long-term medical, developmental, and
mental health outcomes for children with CZS and their families using innovative approaches, such as a
novel heart-rate variability paradigm, that address specific challenges in accurately assessing the
development of children with severe disabilities. Lastly, we will examine malleable predictors of outcomes for
children and their families. This study has the potential to contribute to global knowledge that could lead to
improved outcomes for children and families living with CZS and for children impacted by other conditions
with similar clinical findings.

Public health relevance
PROJECT NARRATIVE In collaboration with the Altino Ventura Foundation, RTI International will continue to evaluate the impact of severe congenital Zika syndrome (CZS) on the development and well-being of 187 children and their families as the children enter middle childhood and enroll in school, focusing on the evolution of structural features of CZS (brain, ocular, orthopedic), long-term medical, developmental and mental health outcomes for children and their families, and predictors of these outcomes. Through this research, we will better understand the natural history of CZS and any factors that may be associated with specific health outcomes, which will help inform and prepare the global community to better support children and families currently living with CZS, potential future cases of CZS, and children impacted by other conditions with similar clinical findings.